Provision of Phlebotomine Sand Flies for the MID-BRR (BEI) Repository

To provide a resource of sand fly species (Phlebotomus papatasi, Phlebotomus papatasi, Lutzomyia longipalpis, Phlebotomus duboscqi, Phlebotomus sergenti, Phlebotomus arabicus) for NIH requesters.